Neuroprotection from ETOH-mediated apoptosis: Nrf2/ARE control of GSH homeostasis

DESCRIPTION (provided by applicant): The proposed studies will elucidate fundamental mechanisms underlying regulation of neuron glutathione (GSH) homeostasis in response to ethanol (E) and will enable augmentation of these systems to enhance neuroprotection. A key transcription factor regulating GSH homeostasis is Nrf2 which drives requisite transcriptions via binding to the antioxidant response element (ARE). Hypothesis. The central hypothesis is that components of the 3-glutamyl cycle, including internal cellular GSH homeostasis components in neurons, can be up-regulated to protect neurons from E-related apoptotic death. Experiments will define essential mechanisms of ARE-dependent regulation of these components and extend this to interventions that will mitigate E-mediated apoptotic death of neurons. Methods. In vivo studies will utilize rat and mouse binge models. In vitro models will be primary cultures of fetal cerebral cortical neurons. Approaches will include transfections with WT and dominant negative controls, RNA silencing, RT-PCR, luciferase assays, and gel shifts. Specific Aim 1: To address the hypothesis that alleviation of ethanol-related damage to neurons can be achieved by optimizing specific components of neuron GSH homeostasis machinery, at the Nrf2/ARE level. The intent is to utilize the Nrf2/ARE cytoprotective system to prevent E-mediated apoptotic neuron death at two levels; first by increased expression of enzymes controlling GSH synthesis and its reduced state ( 3-glutamyl cysteine ligase, glutathione reductase) and second by enhancing regulation of a GSH scavenging system (;-glutamyl transpeptidase (3GT), and aminopeptidase N. Experiments will define mechanisms of ethanol effects on transcriptional and posttranscriptional events controlling expression of these proteins. They will develop means to mitigate E-induced apoptotic death by manipulating Nrf2/ARE driven transcription at key control points of neuron GSH homeostasis machinery. Specific Aim 2. To determine mechanisms by which ethanol impacts on Nrf2 expression in the neuron. Preliminary studies show that E elicits the up-regulation of Nrf2 protein in neurons which could occur at transcriptional and/or posttranscriptional levels. However, this is insufficient to optimally protect the cells from ethanol-mediated apoptotic death. Thus, we will elucidate how ethanol impacts on Nrf2 expression, with the intent of ultimately enhancing neuroprotective potential. Regulation of Nrf2 will be addressed first by post-translational modifications, Keap1 dependent redox switching, and ubiquitination, and second by regulation at the promoter level. Specific Aim 3. To extend these concepts to the live animal using a well-documented rat model and a transgenic mouse model (Nrf2-/-). Experiments will test the hypothesis that Nrf2 activation in the developing brain enhances protection against E-mediated neuron damage. These studies will determine developmental profiles of controlling components of GSH homeostasis, their responses to E, the role of Nrf2 and 3GT in cytoprotection from E, and means to enhance this neuroprotection.

Public health relevance
PUBLIC HEALTH RELEVANCE: The intent of the proposed studies is to elucidate fundamental mechanisms underlying neuroprotective regulation of glutathione (GSH) homeostasis in response to ethanol and to develop strategies to enhance these systems to protect neurons from ethanol-mediated apoptotic death and oxidative damage. In response to stressors, an extensive array of cytoprotective genes is activated in neurons, including those which regulate neuron GSH homeostasis. The key transcription factor controlling this response is Nrf2 which drives requisite transcriptions via binding to a cis regulatory unit, the antioxidant response element (ARE). We have shown that ethanol-mediated death of neurons can be blocked by a GSH homeostasis system and preliminary data illustrate that this neuroprotection can be provided within the neuron itself. It is mediated by Nrf2/ARE driven gene expressions which can be controlled. Linterventions will utilize augmentation of the "3-glutamyl cycle" or its components which will be manipulated at the molecular level. Project Narrative The intent of the proposed studies is to elucidate fundamental mechanisms underlying neuroprotective regulation of glutathione (GSH) homeostasis in response to ethanol and to develop strategies to enhance these systems to protect neurons from ethanol-mediated apoptotic death and oxidative damage. In response to stressors, an extensive array of cytoprotective genes is activated in neurons, including those which regulate neuron GSH homeostasis. The key transcription factor controlling this response is Nrf2 which drives requisite transcriptions via binding to a cis regulatory unit, the antioxidant response element (ARE). We have shown that ethanol-mediated death of neurons can be blocked by a GSH homeostasis system and preliminary data illustrate that this neuroprotection can be provided within the neuron itself. It is mediated by Nrf2/ARE driven gene expressions which can be controlled. Iinterventions will utilize augmentation of the "γ-glutamyl cycle" or its components which will be manipulated at the molecular level. __SpecificAimsTextDelimiter__ SPECIFIC AIMS This proposal is the final submission of a competing renewal of a project that defined mechanisms underlying ethanol mediated apoptotic death of neurons and illustrated the vital role of neuron glutathione (GSH) homeostasis in mitigating the apoptotic pathways that are activated by ethanol-related oxidative stress. The proposed studies are a direct extension of this and will elucidate fundamental mechanisms underlying regulation of neuron GSH homeostasis in response to ethanol. They will enable augmentation of these systems to enhance protection of neurons from ethanol-mediated oxidative damage and apoptotic death. Background and Significance. Aberrant apoptosis of neurons in the developing brain has been shown to be a cause of loss of neurons exposed to ethanol. In response to stressors, an extensive array of cytoprotective genes is activated in neurons, including those which regulate GSH homeostasis. The key transcription factor controlling this response is Nrf2 which drives requisite transcriptions via binding to a cis regulatory unit, the antioxidant response element (ARE). Previous studies have shown that ethanol-mediated death of neurons can be blocked by augmentation of a GSH homeostasis system which is independent of the astrocyte. It is mediated by Nrf2/ARE driven gene expressions which can be enhanced. Hypothesis. The central hypothesis is that components of the γ-glutamyl cycle that maintain internal cellular GSH homeostasis components in neurons, can be expressly up-regulated to protect the cells from ethanol-related apoptotic death. Experiments will define fundamental mechanisms of ARE-dependent regulation of these components. They will extend this understanding to development of interventions that will mitigate ethanol-mediated apoptotic death of neurons that is connected to oxidative damage. Experiments will address these systems within the neuron since, during early brain development, supporting astrocytes are not present or are in low abundance. These in vitro findings will be extended to the whole animal. Specific Aim 1. To address the hypothesis that alleviation of ethanol-related damage to neurons can be achieved by optimizing specific components of neuron GSH homeostasis machinery at the Nrf2/ARE level. The intent is to gain control of the Nrf2/ARE cytoprotective system in order to enhance protection of neurons from ethanol-related damage. This is at two levels. The first is by up- regulation of expression of enzymes controlling GSH synthesis and maintaining its reduced state (γ-glutamyl cysteine ligase, glutathione reductase) and the second is by enhancing regulation of components of a GSH scavenging system (γ-GT, and aminopeptidase N). Preliminary data show that ethanol up-regulates these enzymes in neurons yet many still die. However, if we enhance this up-regulation by adenovirus mediated overexpression of Nrf2, GSH content remains normal and complete protection against ethanol occurs. Experiments will define mechanisms of ethanol effects on transcriptional and posttranscriptional events controlling expression of these proteins. They will develop means to mitigate ethanol-induced apoptotic death by manipulating Nrf2/ARE driven transcription at key control points of neuron GSH homeostasis machinery. Specific Aim 2. To determine mechanisms by which ethanol activates Nrf2 expression in the neuron. Control of Nrf2 expression is central to the cytoprotective responses to ethanol. Preliminary studies show that ethanol elicits a degree of up-regulation of Nrf2 protein in cerebral cortical neurons and that this may be mediated by transcriptional and/or posttranscriptional events. Enabling the neuron to more effectively up-regulate Nrf2 activation would enhance neuroprotection. Regulation of Nrf2 will be addressed at two levels. The first is by post-translational modifications, Keap1 dependent redox switching, and ubiqutination. The second is by regulation of transcription at the promoter level. Specific Aim 3. To extend these concepts to the live animal using a well-documented rat model and a transgenic mouse model (Nrf2-/-). Experiments will test the hypothesis that Nrf2 activation in the developing brain enhances protection against E-mediated neuron damage These studies will determine developmental profiles of controlling components of GSH homeostasis, their responses to E, the role of Nrf2 and γGT in cytoprotection from E, and means to enhance this neuroprotection. Conceptual and Functional Connections of the Specific Aims. Aim1 will elucidate mechanisms by which we can manipulate the GSH homeostasis- related products of Nrf2/ARE interactions in neurons to protect against ethanol. Aim 2 takes a different, but functionally related approach in that it addresses mechanisms of neuroprotection that are connected to activation of the transcription factor Nrf2 and its protein. Aim 3 connects to the first two Aims, the obligatory in vitro studies, by translating the understandings that result to the in vivo setting and to an intervention.